Pilot Project Program

ABSTRACT – PILOT PROJECT PROGRAM
The Pilot Project Program is essential to advancing the mission of the UCSF Environmental Research and
Translation for Health (EaRTH) Center, which was founded in 2020. By soliciting, funding and supporting
new research projects in environmental health, the Pilot Project Program advances three of the four goals of
the EaRTH Center: (1) catalyzing new environmental health research by providing support, technologies, tools,
and expertise; (2) fostering collaborations between historically separated scientific disciplines and clinical,
policy and community members; and (3) mentoring and growing the next generation of environmental health
researchers and clinical leaders. During the first four years of the EaRTH Center, the Pilot Project Program
cast a wide net across UCSF to solicit innovative research projects of $50,000 and smaller Mentored Awards
for researchers and clinicians, plus a Community Partnership award. We issued a total of 21 awards at a total
of $818,000. We extended our EaRTH funds available by 17% with four co-funding partnerships within UCSF.
Among project PIs and co-PIs, 12/30 were new to environmental health, 60% of lead PIs were early-stage
investigators (ESIs) and half actively work in the clinic in addition to performing research. Focal areas of our
research portfolio include exposures relevant to California (wildfires, climate change and chemicals), health
equity and non-chemical stressors, pregnancy and childhood exposures, and population health outcomes
including cancer, birth outcomes, and neurologic conditions, with a number of these assessing biological
pathways including the proteome and metabolomics. We funded two innovative community engaged projects,
one led by a community group engaging public housing participants in climate resilience and environmental
sustainability training; and another creating resources on strategies to remain healthy during heat waves for
vulnerable populations, translated into Spanish and a Chinese-translation developed with local high school
students. EaRTH funds and Center engagement already resulted in our awardees publishing 48 papers,
submitting 88 grants, of which 25 were awarded, totaling ~$9.1M which is a more than 10-fold return on
investment. This renewal application builds upon the Pilot Project Program’s track record in cultivating a
thriving community of environmental health research at UCSF with continued co-funding with the UCSF P30
Nutrition and Diabetes Research Center and Program for Breakthrough Biomedical Research and new
partnerships with the UCSF Institute for Global Health Sciences and Bixby Center for Global Reproductive
Health and the Institute for Regeneration Medicine to complement the newly added human Organoid Foundry
service offered through our Bioassay Facility Core. Through our innovative structure for soliciting, selecting and
supporting projects, we will continue to fuel environmental health research at UCSF with high impact by
supporting early-stage investigators, fostering interdisciplinary collaboration, and funding high-risk/high-reward
projects.